VitC to Decrease Effects of Smoking in Pregnancy on Infant Lung Function-CCC-Lead

DESCRIPTION (provided by applicant): This is a application for a double blind, placebo-controlled study to determine if vitamin C supplementation (500 mg daily) can decrease the effect of maternal smoking in pregnancy on offspring pulmonary function (VC-SIP). Smoking during pregnancy remains a major public health problem as at least 12% of pregnant women cannot quit smoking during pregnancy. This addiction is the largest preventable cause of childhood respiratory illness, including asthma, and children whose mothers smoked during pregnancy show lifetime decreases in pulmonary function. Smoking is a unique morbidity in that it is addictive, heavily advertised and recent genome studies show there are genotypes that significantly increase the likelihood of being unable to quit. Teen pregnancy, low income, low education, and living with another smoker are important factors increasing the odds of smoking during pregnancy. Pulmonary function tests done shortly after birth in babies born to mothers who smoked during pregnancy show decreased pulmonary function as measured by decreased respiratory flows and compliance and altered tidal breathing patterns. These changes can still be measured even after the infants have reached adulthood. Multiple epidemiologic studies show that these decreases in pulmonary function lead to increased respiratory disease and costs of hundreds of millions of dollars per year. The primary aim of this multi-site study is to demonstrate improved pulmonary function testing at 3 months of age, in infants delivered to smoking mothers who are randomized to 500 mg/day of supplemental vitamin C versus placebo prior to 22 weeks of pregnancy. Patients will meet with research personnel at each prenatal visit and smoking cessation will be actively encouraged. Patients will be monitored with a set of serial biomarkers to assess smoking and medication compliance, including urine cotinines levels, smoking questionnaires, pill counts and fasting plasma ascorbic acid levels. Pulmonary function tests will be done at 3 months of age and will measure forced expiratory flows. Success of this study is supported by strong pilot data from Dr. McEvoy's K23 showing statistically significant improvements in pulmonary function tests in infants born to smoking mothers who received vitamin C, and preliminary data showing a lower incidence of wheezing at 1 year of age in these infants. Key genetic polymorphisms shown to increase sensitivity to in utero smoke exposure will also be measured. The success of this study is also supported by animal models showing the effectiveness of vitamin C to preserve pulmonary function and genetic and epidemiologic studies linking the effects of smoking during pregnancy to oxidant mechanisms. Given nicotine's addictive nature, the underserved socio-economic nature of the patient population, and the constant advertising by tobacco companies, smoking during pregnancy will continue to adversely victimize millions of babies worldwide. This research has great public health significance to potentially alter the fetal origins of respiratory disease by blocking some of the effects of in-utero smoke exposure on lung development.

Public health relevance
PUBLIC HEALTH RELEVANCE: Maternal smoking during pregnancy is the largest preventable cause of childhood respiratory illness, and children whose mothers smoked during pregnancy show lifetime decreases in pulmonary function and increased respiratory illnesses and asthma. Maternal smoking is estimated to cause 10% of direct medical expenditures in the first year of life and approximately 20% of expenditures for childhood respiratory illness are caused by maternal smoking. The findings from this project will support the addition of a simple, safe, and inexpensive adjunct to current smoking cessation counseling that would significantly decrease the impact of smoking during pregnancy on child respiratory health both in the US and world-wide. (End of Abstract) __SpecificAimsTextDelimiter__ Specific Aims: The objective of this multi-site, clinical study is to determine the efficacy of maternal vitamin C supplementation (500 mg) to prevent the effects of maternal smoking in pregnancy (VCSIP) on their infant's pulmonary function, as measured at 3 months of age. We will also evaluate the effect of vitamin C on the incidence of wheezing, as an important predictor for subsequent respiratory morbidity, in these infants through 12 months of age. Despite strong anti-smoking efforts, at least 12% of American women do not/ can not quit smoking when pregnant, resulting in more than 450,000 smoke-exposed infants born yearly.9 From 2000 to 2005, the rate of smoking during pregnancy decreased by only 1.4% and over 60% of female smokers continue to smoke while pregnant.9 Moreover greater than 20% of pregnant smokers will deny smoking 10;11 suggesting the true incidence is higher. Smoking during pregnancy is the single most preventable cause of perinatal mortality and increases preterm delivery, intrauterine growth retardation and sudden infant death syndrome.12 Maternal smoking during pregnancy adversely affects lung development as seen by lifelong decreases in pulmonary function and increased risk of asthma.13;14 At birth, infants born to smoking mothers show decreased pulmonary function with decreased respiratory flows and compliance, and altered tidal breathing patterns. These changes lead to increased wheezing, hospitalization for respiratory infections, and increased incidence of childhood asthma, all amounting to at least $660 million per year in 1997 health care dollars.15 Given the above, the obvious question is: why can't pregnant women stop smoking and if they don't, why should we invest research dollars? The reality is that smoking is a unique morbidity in that it is addictive, heavily advertised, and recent genome association studies show there are genotypes that significantly increase the likelihood of nicotine addiction / failure to quit.16-19 Teen pregnancy, low income, low education, and living with a smoker all increase the odds of smoking during pregnancy. Given nicotine's addictive nature, the underserved socio-economics of the patient population, and the constant advertising by tobacco companies, smoking during pregnancy will continue to adversely affect millions of babies worldwide. These unfortunate realities make finding ways to lessen the impact of smoking during pregnancy of vital importance. The likely success of this vitamin C supplementation is supported by preclinical work from Dr. Spindel in nonhuman primates 20;21 and by exciting pilot clinical data from Dr. McEvoy. Based on the successful trial of vitamin C in pregnant monkeys,20 Dr. McEvoy commenced a translational K23 project in which a sample size of 154 pregnant smoking women were randomized to vitamin C (500 mg) or placebo. The planned enrollment was reached and all mothers have delivered and results demonstrated a significant improvement in pulmonary function in infants born to smoking mothers who received vitamin C. In addition, the pilot data showed a lower incidence of wheezing at 1 year of age in the infants whose mothers received vitamin C. Participation in the study did not give the smoking mother license to continue smoking, as smoking cessation was emphasized throughout the study and resulted in typical quit rates. This research has great public health significance to potentially alter the fetal origins of respiratory disease by blocking some of the effects of in-utero smoke exposure on lung development. These findings would change health care practice, particularly in view of the risk to benefit ratio, and the interest of obstetricians in pursuing dietary interventions to decrease disease in pregnancy.1;3 The findings would support the addition of a simple, safe, and inexpensive adjunct to current smoking cessation counseling that would significantly decrease the impact of smoking during pregnancy on child respiratory health. Finally the potential for worldwide impact of this trial, if successful, is very large. Importantly, the safety of this study is backed by the lack of adverse events in a recent multi-center trial of 10,000 pregnant women who received a larger dose of vitamin C than planned here as part of a study to prevent preeclampsia.3 Therefore we propose the following specific aims: Specific Aim 1 (Primary Outcome): The primary aim of this study is to demonstrate improved pulmonary function at 3 months of age in infants delivered to smoking mothers who are randomized to 500 mg/day of supplemental vitamin C versus placebo during pregnancy. We hypothesize that vitamin C supplementation during pregnancy will block the adverse effects of maternal smoking on infant pulmonary function measured at 3 months of age (forced expiratory flows) in infants born to smoking women. Specific Aim 2: The secondary aim of this study is to demonstrate a decreased incidence of wheezing through 12 months of age in infants delivered to smoking mothers who are randomized to 500 mg/day of supplemental vitamin C versus placebo during pregnancy. We hypothesize that vitamin C supplementation during pregnancy will decrease the incidence of wheezing in the first 12 months of life in offspring of smokers.